Ecological dynamics and metabolic interactions in thegut microbiome across space and time

SUMMARY
It is now recognized that instability and dysbiosis of physiologically important communities, such
as the gut microbiome, may contribute to a wide range of human disease, from immune disorders
to psychiatric phenotypes to obesity. This is a problem of preeminent medical importance as
dietary imbalances, shaping the identity and abundance of resident bacteria, affect the health of
many millions of Americans on a daily basis. Despite the underlying complexity, our preliminary
analyses revealed that the dynamics of gut bacteria can be in fact described by several robust
statistical relationships. Moreover, the relationships characterizing microbiota fluctuations are
strikingly similar to patterns previously observed across multiple other ecological and economic
systems. We have also recently developed novel high-throughput experimental and
computational approaches to characterize likely metabolic interactions at the micron scale and
across different diets. We propose to use an integrated computational and experimental approach
to comprehensively investigate diet-dependent dynamics and stability of gut microbiota: Aim1.
Develop and implement a set of complementary computational approaches for probabilistic
prediction of microbial metabolic phenotypes. Aim2. Collect temporal data on absolute bacterial
abundances in the gut across several health-related diets and common prebiotic supplements in
mice models. Apply a quantitative ecological framework to comprehensively investigate
microbiota stability and dynamics on different diets. Aim 3. Collect spatial co-localization
information on the micron scale and across multiple diets. Combine co-localization with
probabilistic metabolic annotations to investigate the nature of potential cooperative and
competitive metabolic interactions between microbial species in the gut. Investigate the diet-
dependent stability of bacterial interactions in space and time. Close the experimental-
computational loop by validating several dozens of high-confident interactions in vitro.!

Public health relevance
NARRATIVE In the proposal we will use an integrated computational and experimental approach to comprehensively investigate diet-dependent dynamics and stability of gut microbiota. We will also investigate the nature and stability of bacterial metabolic interaction in the gut across diets.